Uncovering the Molecular Determinants of Cell Type-Specific Connectivity

The numerous functions of the brain are carried out by circuits that are very precisely wired. Within a brain region, there can be hundreds of distinct cell types, but a specific pathway may only innervate some cell types and not others. These synaptic connectivity patterns are largely established during development by the interactions of varied pre- and postsynaptic cell adhesion molecules (CAMs) expressed by each cell type. Large-scale transcriptomic atlasing methods have now described thousands of cell types, with hundreds of CAM genes expressed throughout the brain. Consequently, uncovering the CAMs essential for establishing cell type-specific connections onto neuronal populations has proved incredibly challenging. Tackling this research area requires two key methodological advancements. First, it necessitates the development of a high-throughput method for mapping connectivity across transcriptomically defined cell types. I recently developed such an approach by leveraging all-optical tools for scalable synaptic mapping (SynMap) across a neuronal population. With SynMap, I can measure postsynaptic responses of < 0.25 mV across hundreds of cells per experiment, and determine the identity of each cell using spatial transcriptomic methods. But understanding how these circuits are constructed now requires the development of a second technology for screening the functional roles of many molecules across an entire population of cells in intact tissue. To this end, in the K99 phase of this proposal I will demonstrate in vivo Perturb-FISH, a method for performing and characterizing stochastic CRISPR-based genetic perturbations across distinct cell types in the brain using spatial transcriptomics. In the independent R00 phase of this work, I will combine Perturb-FISH and SynMap to determine which CAMs are essential for establishing cell type-specific synaptic connections between the motor thalamus and the motor cortex– a pathway in which cell-type specific wiring is thought to be crucial for circuit function. The general connectivity principles that I uncover as part of this study will greatly advance our understanding of the molecular basis of cell type-specific wiring throughout the brain.

Public health relevance
Project Narrative To form the brain circuits that will eventually carry out all neural functions, different types of neurons must precisely wire together. But the specific molecules that are responsible for forming connections between some cells and not others have not yet been identified due to a lack of scalable tools. In this proposal, I will uncover the molecular logic of cell type-specific connectivity by using efficient and state-of-the-art tools for screening the role of individual molecules, and visualizing both neuronal connectivity and cell type identity at scale.